Metaorganismal TMAO pathway driving scleroderma pathogenesis: novel gene-environment interaction paradigm and therapeutic target

PROJECT SUMMARY/ABSTRACT
Systemic sclerosis (SSc) is a prototypic fibrotic illness affecting virtually every organ. Genetic and environmental
factors both contribute to disease. In addition to fibrosis, vascular injury and gut dysbiosis are prominent;
however, how these distinct processes are governed by gene-environment interactions, and how they are linked
together in pathogenesis is largely unknown, precluding development of disease-modifying therapy. Based on
remarkable recent data from our lab and others, we now propose a novel paradigm for the elusive gene-
environment interaction in SSc that ties gut microbial metabolism to vascular injury and fibrosis and opens the
door for innovative therapy: 1) gut microbiota exposed to a Western diet generate trimethylamine (TMA), which
is converted in the host to trimethylamine N-oxide (TMAO) by the enzyme flavin-containing monooxygenase
(FMO3). Elevated TMAO is associated with endothelial cell injury, promotion of fibrotic cellular phenotypes, and
tissue fibrosis; 2) genetic variants of FMO3 show highly significant association with SSc; and 3) expression of
FMO3 is significantly upregulated in SSc skin fibroblasts. Our hypothesis is that choline-rich diets via a
metaorganismal axis generate elevated TMAO, which promotes vascular injury and organ fibrosis via
endothelial-mesenchymal transition (endoMT) and other pathways implicated in SSc pathogenesis. We propose
that the fibrotic propensity can be mitigated by selectively inhibiting gut TMA lyase, the microbial enzyme
exclusively responsible for TMA generation. This represents a distinct and transformative treatment paradigm.
During the first two years (R61 phase), we will determine if and how diet-dependent chronic TMAO elevation
impacts fibrosis in distinct in vivo disease models and explanted cells. We will then evaluate if a translationally-
relevant novel compound that selectively inhibits TMA lyase in the gut modifies these responses. We will
determine whether endoMT represents a key mechanism linking diet-associated TMAO elevation and vascular
injury and fibrosis. In Year 3 (R33 phase), undertaken upon achieving our predefined milestones, we will define
the role of FMO3 in diet-induced fibrosis propensity, and determine if circulating TMAO is a potential diagnostic
and prognostic biomarker of SSc and its endotypes in both cross-sectional and longitudinal studies. This project
seeks to validate an entirely novel SSc paradigm that links the environment/diet and genetic risk (FMO3 variants)
in a metaorganismal pathway that underlies SSc pathogenesis and can be selectively targeted for therapy.

Public health relevance
PROJECT NARRATIVE New approaches for developing disease-modifying therapy in scleroderma (systemic sclerosis, SSc) are urgently needed. This application seeks to generate data for an entirely novel paradigm for the elusive gene- environment interaction in SSc that ties the diet and gut dysbiosis to vascular injury and fibrosis underlying SSc pathogenesis. Our high risk, high reward approach is fundamentally different from traditional reductionist strategies and seeks to integrate environmental dietary factors (via gut microbial TMA generation from nutrient in the western diet) with enhanced host TMA metabolism (via genetic variant of FMO3) in a metaorganismal pathway that drives disease and to develop novel approaches for pharmacological disease-modifying therapy.